Supplement: 53BP1 regulates genome biology and cellular physiology through liquid phase separation

Humans inevitably age, and often develop cancer. A fundamental cause of aging and cancer is the loss of
genome stability (abnormalities in nuclear DNA or chromosomes). Hence, understanding mechanisms
regulating genome stability has huge impact on biology and human health. Hypothesis related to genomic
instability generation and cancer evolution has long been revolved around the DNA damage response and
repair programs that control DNA metabolism. Our recent findings indicate an important role of liquid phase
separation, an emerging biological process by which proteins and nucleic acids form membraneless liquid
droplets/condensates inside cells to respond to environmental and internal cues, in regulating genome stability.
We demonstrated that this activity preserves the structure and the function of heterochromatin through a
protein called 53BP1; importantly, this new protective activity of 53BP1 is independent of its widely known role
in DNA double strand break (DSB) repair (Nat Communications, 2022). Hence, our results open a new
research paradigm in studying genome stability regulation and stress response. The overarching goal of this
application is to establish this research paradigm by understanding the mechanism and the impact of 53BP1
liquid phase separation. Two Aims are proposed. Aim 1 will determine how exactly 53BP1 phase separates
at heterochromatin. Aim 2 will determine the biological significance of 53BP1 phase separation. By
assembling an interdisciplinary team consisting of experts on molecular and cellular biology, proteomics,
computational bioinformatics, and next generation sequencing, we will use a combination of cell biological,
molecular, biochemical, genetic, morphological, and chemical approaches to answer these questions. Upon
completion, our studies will illustrate a previously uncharacterized function of 53BP1 and a novel interplay
between 53BP1 and heterochromatin and determine their impact on genome stability, facilitating our
understanding of fundamental cellular information processing, cellular homeostasis, and cellular physiology. To
the best of my knowledge, no other investigators are working on this research direction.

Public health relevance
Identifying molecular mechanisms underlying chromosome integrity under normal physiology and during stress response is critical for our understanding of genome biology, cellular homeostasis, and physiology. This proposal will establish a leading edge on regulatory mechanisms of human genome based on our recent findings. Upon completion, this study will reveal innovative insights into the maintenance of DNA structure, stress response, and genome stability, representing a conceptual leap in our understanding of biology and cellular physiology.